Optimization and Normalization Studies for CSF as a Biomarker

DESCRIPTION (provided by applicant): Alzheimer's disease (AD) is the most common form of dementia and is the sixth leading cause of death in the United States. The greatest known risk factor for AD is increasing age; the majority of people with AD are age 65 and older. AD is a progressive disease, with dementia symptoms gradually worsening over several years. Current AD treatments cannot stop disease progression, but they can temporarily slow the progression of dementia symptoms and improve quality of life for those with AD and their caregivers. There is no diagnostic biomarker that can be used to predict the onset of AD, nor is there a biomarker which can distinguish early AD from age-related dementia. Such a discriminatory tool would be invaluable in guiding clinicians towards early interventional efforts. The existence of extracellular RNAs in biofluids represents a fertile molecular landscape from which diagnostic and prognostic biomarkers may be isolated, characterized, and exploited. Accordingly, the identification of extracellular RNAs in the cerebrospinal fluid (CSF) provides an opportunity to define important biomarkers for clinical use in characterizing dementias such as AD. MicroRNAs are members of the non-protein-coding family of RNAs that serve as regulators of post-transcriptional gene expression. MicroRNAs are increasingly being identified in circulating fluids such as CSF, plasma, serum, and placental tissue, where their expression is correlated with several diseases including brain injury, degenerative diseases, and mental health disorders. We propose to identify microRNAs in CSF to examine their utility as diagnostic biomarkers for AD. To achieve this goal, we have established a highly qualified, multidisciplinary investigative team with expertise AD, dementia, and CSF biomarkers, advanced genomic methodologies, biostatistics, and clinical studies to examine the clinical utility of microRNAs in CSF as diagnostic biomarkers for AD.

Public health relevance
PUBLIC HEALTH RELEVANCE: Alzheimer's disease (AD) is a progressive brain disorder that damages and eventually destroys brain cells, leading to memory loss and cognitive decline. Current diagnosis of AD relies largely on documenting mental decline, which itself is not apparent until severe, irreversible brain damage has occurred. Recent studies have shown that extracellular RNAs in biofluids are correlated with disease states, suggesting a potentially important role for these products as diagnostic biomarkers for human disease. Thus, the proposed studies will examine a specific class of extracellular RNAs - microRNAs in cerebrospinal fluid - for their clinical utility as diagnostic biomarkers for AD, a matter of substantial medical importance to patients, their families, and society at large. __SpecificAimsTextDelimiter__ Specific Aims Alzheimer's disease (AD) is the most common form of dementia and is the sixth leading cause of death in the United States. The greatest known risk factor for AD is increasing age; the majority of people with AD are age 65 and older. AD is a progressive disease, and dementia symptoms gradually worsen over several years. Memory loss is mild in early-stage AD, but individuals with late-stage AD lose the ability to carry on a conversation and respond to their environment. Current AD treatments cannot stop disease progression, but they can slow the worsening of dementia symptoms and improve quality of life for those with AD and their caregivers. To date, there is no diagnostic biomarker that can be used to predict the onset of AD. However, a clinical tool that could distinguish early AD from other age-related dementias would be invaluable in that AD treatments could be initiated earlier to slow disease progression in its earlier stages, a matter of utmost importance to AD patients and their families, and society at large. The existence of extracellular RNAs in biofluids represents a fertile molecular landscape from which diagnostic and prognostic biomarkers may be accessed, characterized, and exploited. Accordingly, the identification of extracellular RNAs in the cerebrospinal fluid (CSF) provides an opportunity to define important biomarkers that characterize and differentiate dementias such as AD. MiRNAs are one such example of extracellular RNAs, and are being increasingly found in circulating biofluids such as CSF, plasma, serum, and placental tissue, where their expression is correlated with several diseases including brain injury (traumatic brain injury, ischemia), degenerative disease (multiple sclerosis and AD), and mental health disorders (bipolar disorder). MiRNAs are members of the non-protein-coding family of RNAs that serve as regulators of post-transcriptional gene expression. Importantly, miRNAs are stable in circulating fluids, presumably because they are contained within ribonucleoprotein complexes which afford them protection against nuclease digestion. We propose to identify miRNAs in CSF to examine their utility as diagnostic biomarkers for AD. To achieve this goal, we have established a highly qualified, multidisciplinary investigative team with expertise AD, dementia, and CSF biomarkers (Dr. Quinn), in advanced genomic methodologies to examine miRNA expression (Dr. Saugstad), and in bioinformatics (Dr. Lusardi) and biostatistics (Dr. Lapidus). We propose to accomplish the following aims: UH2 (Stage 1) The exploratory pre-clinical studies in stage 1 will examine miRNA expression in existing CSF samples obtained from living donors to assess the utility of miRNAs to discriminate between subjects with a clinical diagnosis of AD and healthy control subjects. Aim 1. Examine the expression of all known human miRNAs in CSF using Taqman miRNA qRT-PCR arrays on existing CSF samples isolated from healthy subjects and AD patients obtained from the Oregon Alzheimer's Disease Center (OADC). Aim 2. Perform statistical analysis of the Taqman qRT-PCR array datasets to identify miRNAs that are differentially expressed in AD versus healthy subjects and that serve as high-priority candidates for clinical utility as diagnostic biomarkers of AD. Aim 3. Examine the expression of specific, high-priority miRNAs using individual qRT-PCR assays on a new set of CSF samples isolated from healthy subjects and AD patients obtained from the OADC. UH3 (Stage 2) The demonstration pre-clinical studies in Stage 2 will examine miRNA expression in a newly obtained set of CSF samples to validate the utility of high-priority miRNA candidates as robust biomarkers of AD and to determine their capacity to detect preclinical AD in a new set of CSF samples. We will verify results from UH2 using new samples obtained from the OADC. We will also design another case-control study with Alzheimer's Disease Neuroimaging Initiative (ADNI) samples. We will use a more "population-based" cohort with a combination of OADC and ADNI samples to estimate performance of individual or composite signatures of multiple miRNAs. Aim 1. Leverage the ongoing recruitment and retention of participants in the OADC to obtain a new bank of CSF samples to validate high-priority miRNA candidates as diagnostic biomarkers for AD. Aim 2. Expand miRNA expression studies to include CSF from patients diagnosed with Mild Cognitive Impairment (MCI) using samples obtained from the ADNI, and identify potential variation between and within OADC and ADNI centers with respect to miRNA testing. Aim 3. Assess the correlation between secondary factors (sex, age, medications, co-morbid conditions, APOE gene status, MRI) and miRNA expression in healthy subjects.